Interdisciplinary Training in Auditory Neuroscience

PROJECT SUMMARY/ABSTRACT
There is a national need to advance the understanding of hearing in both healthy patients and those with various
causes of hearing loss, which contribute to reduced quality of life and are correlated with much poorer health
outcomes. The objective of this continuing training program is to train the next generation of faculty who will
populate colleges of science, engineering, and health sciences, as well as to send graduates into industry
prepared to work toward creative solutions for treating hearing loss. Specifically, in order to advance auditory
neuroscience training, this graduate training program leverages faculty expertise in both basic hearing science
and technology development, from three Purdue University colleges (Science, Engineering, and Health & Human
Sciences) and 8 doctoral admissions programs. Two types of investigators are included: 10 hearing scientists
with focused research programs related to auditory-system neuroscience, and 12 technology innovators trained
in other disciplines (e.g., biomedical and electrical engineering, computer science). Collectively and
collaboratively, the program expands knowledge about mechanisms at the molecular, cellular, and systems
levels that underlie auditory information processing. This fundamental knowledge can then be applied to better
understand the changes that lead to pathologies of the auditory system due to damage, disease, aging, and
congenital disorders, as well as understanding how hearing evolved and influences behavior and natural
selection. Technological approaches to these questions include, but are not limited to, super-resolution
microscopy, biological implants for neuromodulation, high-resolution four-dimensional calcium imaging deep in
the mammalian brain, optogenetics and robotics (automated patch-clamping) for brain circuit analysis, and
multimodal brain imaging methods, coupled with advanced approaches in statistical and data analysis and model
development. TPAN is unique in that it is specifically designed to serve students with undergraduate degrees in
the disparate disciplines of life science, physical science or engineering, and merge them into a unified cohort
focused on auditory neuroscience. Four fellows are selected for a 2-year term on the training grant, beginning at
the start of their second year. The training curriculum includes 4 core courses (one each in neuroscience, the
auditory periphery, central/behavioral auditory science, and signal processing), a required grant-writing course,
a weekly Hearing Science seminar series where students and faculty present, and yearly attendance at
extramural training courses and/or auditory-neuroscience conferences. Vertical and horizontal mentoring provide
training and support at all levels, to enhance scientific networks, and to foster a sense of community among all
hearing-science students (current and recent TPAN fellows, plus TPAN affiliates) that promotes success in the
PhD and afterwards. Support is provided, in collaboration with Purdue's Institute for Integrative Neuroscience,
for an individual data-management consultant for each Fellow, individually budgeted training-related expenses,
diversity recruiting by both faculty and students, as well as for admininstrative support.

Public health relevance
PROJECT NARRATIVE This Interdisciplinary Training Program in Auditory Neuroscience (TPAN) will provide graduate student training, research experience, and a vibrant community at the interface of neuroscience and neurotechnology, in both human and animal models. This training program will prepare students for independent research careers that can improve our understanding of auditory system function and treatments of auditory system dysfunction using innovative tools and technologies. It is expected that graduates of this training program will develop creative solutions, devices and strategies to advance sensory neuroscience and to ultimately assist and prevent hearing loss in human patients.